S1PR1-targeted PET imaging to predict and monitor response to HER2-targeting antibody-drug conjugates

PROJECT SUMMARY/ABSTRACT – In patients with gastric cancers who are clinically classified as HER2-
positive, antibody-drug conjugates (ADC) prolong progression-free and overall survival. However, not all
gastric tumors benefit from these therapies, or even those who initially respond inevitably develop resistance
over time. Complementary biomarkers and methods are therefore needed to identify patients that will respond
or develop resistance to HER2-targeting ADC therapies. Preclinical data we obtained in HER2 heterogeneous
gastric patient-derived xenografts (PDXs) demonstrate that tumoral sphingosine-1-phosphate receptor
(S1PR1) associate with tumors’ response to ADCs. Here, we will validate a S1PR1-targeted imaging approach
(that is already used in the clinics for non-cancer applications) that allows quantitative measurements of
S1PR1 to evaluate the early response to ADC treatment in mouse models of gastric cancer. We will correlate
HER2 membrane availability, tumoral S1PR1, and the presence of genetic alterations with gastric tumor
response to ADCs. We will perform randomized imaging and therapeutic studies in gastric PDXs to identify
biological features that confer tumor sensitivity and resistance to ADCs. Aim 1 will use molecular imaging
approaches involving positron emission tomography (PET) to further investigate the role of S1PR1 in ADC
efficacy. Our innovative approach can quantitatively measure ADC-tumor binding through immunoPET and
S1PR1 through a radiolabeled small molecule in the same subject and in real-time in gastric PDXs. Our
studies will show that our imaging approaches, combined with analyses at the tissue level, can quantitatively
detect different levels of early response to ADC therapy in gastric tumors, providing a strong impact. Aim 2 will
further establish PET to determine the potential of modulating tumoral S1PR1 to reverse ADC resistance in
gastric tumors. We will measure changes in HER2 and S1PR1 in response to treatments that enhance ADC
efficacy. For each study, we will correlate the magnitudes of changes in our imaging biomarkers to a longer-
term therapeutic outcome, as well as determine which combinations of multiple biomarkers improve the
evaluation of early treatment response. This project could provide an excellent foundation for many future
investigations, including the clinical translation of PET imaging approaches to predict and monitor tumor
response to ADCs and the potential broader application to other membrane receptors and heterogeneous
tumors. The long-term translational objectives of the studies proposed are to establish a foundation for a
clinical study using imaging approaches of antibody-tumor accumulation and S1PR1 as predictive biomarkers
of tumors response to HER2-targeting antibody drugs.

Public health relevance
PROJECT NARRATIVE – The vast majority of patients with advanced gastric cancers become refractory to anti- HER2 antibody-drug therapies. The use of predictive biomarkers to guide antibody-drug response are necessary for improving survival in patients with gastric cancer and for sparing them from unnecessary toxicity. This proposal seeks to optimize a novel non-invasive imaging approach that can identify the sensitivity or resistance of Trastuzumab-drug conjugates in gastric cancer.